The Florida Node Alliance of the National Drug Abuse Treatment Clinical Trials Network

PROJECT SUMMARY/ABSTRACT
This is an application for years 21-25 of NIDA's CTN Florida Node Alliance (FNA). The FNA covers Florida,
Georgia and Puerto Rico, areas of the US that continue to suffer from high rates of drug overdoses and
unceasing opioid, cocaine and methamphetamine epidemics. These areas have unmet treatment needs and
experience disparities in the implementation of evidence-based treatments. The FNA aims to build on our
record of success in leading and implementing trials in healthcare settings and integrating substance use into
mainstream of healthcare. We propose to bring to the CTN the FNA's considerable expertise in adolescent
treatment, the HIV and HCV care continua in substance-using populations, mental health comorbidities, e-
Health, data science, culturalized science, health economics, training, implementation/dissemination, and work
with Hispanic populations. The FNA's research agenda will provide scientific leadership to develop, test, and
implement interventions for the full spectrum of substance use in adolescents and adults, and strategies for the
integration of SU prevention/screening/treatment services into mainstream adolescent and adult health care.
The FNA also aims to apply our expertise in implementation science, data science, and use of electronic health
records (EHRs) to promote learning health care systems that build on precision medicine principles by
implementing and refining methods to predict individual response to treatment. Building on a foundation of
bidirectional collaboration, the FNA proposes to develop, test and implement interventions that address the
service delivery continuum in the FNA's clinical and research networks. These networks consist of SUD
treatment and general medical settings, health systems, clinical research networks, and practice-based
research networks. To achieve its aims, the FNA is proposing an innovative research agenda of concepts that
(1) integrate behavioral health and family focused interventions in pediatric care with the use of e-technologies,
(2) deliver integrative models of care for comorbid SU and HIV in hospital settings, (3) address the
comorbidities of mental health and stimulant use, (4) use EHR, registry and environmental data to improve
treatment precision, and (5) use context and culture to improve treatment outcomes. The FNA proposes to
collaborate with other Nodes on the design and implementation of CTN trials and by providing the
infrastructure and capabilities required for successful study execution. FNA network partners have
demonstrated experience in conducting point of care trials and studies that leverage the use of EHR and
claims data. The University of Miami CTSI, University of Florida CTSI, and the Georgia CTSA, will bring to the
CTN the bioinformatics tools of the CTSA National Consortium. These CTSAs together with partners of the
FNA, facilitate access to a diverse patient population of 16+ million patients across a numerous settings such
as primary care, EDs, hospitals, FQHCs, school-based clinics, SUD treatment and harm reduction venues.

Public health relevance
PROJECT NARRATIVE Our research infrastructure supports the development and implementation of innovative clinical trials to answer a broad spectrum of translational substance abuse treatment research questions across a wide variety of treatment settings and diverse patient populations. Dissemination partners facilitate training in evidence-based treatments to reach non-treatment seeking drug using patients and improve their treatment outcomes.